A prospective examination of stimulant diversion and related risk factors for young adults with childhood- or adult-diagnosed ADHD

Project Summary
Diversion of ADHD stimulants, by sharing, selling, or trading, is the primary conduit by which these
Schedule II controlled drugs reach their peak prevalence of misuse in early adulthood (use without a
prescription, overuse of prescribed medication). Yet, understanding of stimulant diversion and contributing
factors is limited to speculation from small cross-sectional studies. Dramatically increased rates of stimulant
prescribing in recent years (from ~49.2 to 62.8M people), mainly in adults, has heightened concern. The state-
of-science on this important topic precludes development of prevention efforts based on variables with inferred
causal influence. Additionally, although primary care is the most common treatment setting for ADHD, this
population and its risk for diversion in adulthood, including when diagnosis and treatment occurs after childhood,
is poorly understood. Due to concern about these trends and reports of associated physical dangers and legal
consequences, the FDA recently established a public docket requesting comments on the potential role of abuse-
deterrent stimulant formulations. The accompanying review stated a need for information on factors that would
inform their decision-making, including characterization of longitudinal pathways to misuse. The proposed
study prospectively examines stimulant diversion and hypothesized risk factors among young adults at
peak age for stimulant diversion: those initially diagnosed and stimulant-treated in early adulthood, and
those stimulant-treated as adolescents by pediatricians and aging now into early adulthood. The
combined sample will provide a unique opportunity to examine associations between timing of ADHD
treatment, stimulant diversion, and hypothesized risk factors. N=357 adolescents stimulant-treated for
ADHD in primary care (U01 DA040213), and 150 newly recruited young adults first diagnosed and treated
in adulthood, will be studied (total n = 507). Three annual assessments will span ages 18-24 to allow
prospective study of stimulant diversion during the age period of its greatest prevalence. Self- and parent-report
and behavioral economics tasks will be used to assess intrapersonal, attitudinal-behavioral, and social-normative
risk factors and environmental moderators (parenting and provider factors). The results of this study will aide
Priority Focus Area #3 of NIDA’s 2016-2020 Strategic Plan, “Addressing Real World Complexities” by generating
findings that will apply to two of the largest, least understood segments of the treated ADHD population—those
treated in primary care, and those young adult-diagnosed. Findings will provide crucially needed prospectively
gathered data to inform the development of stimulant diversion prevention efforts.

Public health relevance
Narrative Non-prescribed use, for cognitive enhancement (e.g., while studying) or recreation (e.g., partying), of stimulant medications by young adults is a prevalent problem; this Schedule II controlled medication is usually obtained from peers with prescriptions, yet little data are available to explain this diversion behavior. Efforts to prevent stimulant misuse are therefore missing key information. The proposed research will study diversion behavior among young adults with ADHD and its longitudinal predictors to improve the prevention of stimulant misuse and its associated adverse medical and legal consequences.